Fourth-Generation Nanopore-Assisted Sequencing for Advanced Oncological Analyses

Project Summary
Nanopore-based sequencing has numerous advantages over sequencing-by-synthesis (SBS, the current gold
standard for accuracy), including its ability to detect genomic variations (on a single molecule basis) and provide
long-read, wider genomic contexts, and scaffolds. Additionally, the low cost and simple instrumentation mean
that nanopore sequencing can enable accessible and routine clinical cancer screening in the future as
comprehensive, disease-specific assays are developed. However, in order to supplant SBS, nanopore-based
sequencing techniques must see improvements in methodology to increase accuracy, and this is particularly
true for genomic repeats, which represent significant but under-studied regions of the genome. In fact, repetitive
DNA sequences comprise almost 50% of the human genome but are still quite challenging to characterize
because it is impossible confidently align/order small fragments of the repeat; DNA repeats need to be read
continuously and completely (end-to-end). SBS technology specifically is limited by a combination of sequence
bias, and polymerase/synthesis error or failure that accumulates during the sequencing process and ultimately
limit the technique to short read lengths. Thus, because the most accurate sequencing method on the market
(SBS) cannot sequence these regions, their roles in disease progression are largely unknown. However,
evidence to date shows DNA repeats have a remarkable quantity of sequence variation(s) for normal vs.
diseased cells, and as a function of disease progression. Further, these disease-correlated variations have also
been found to indicate therapy success. Unfortunately, the methods used for these studies are primarily
academic in nature, relying on complex, qualitative methods that do not transfer to clinical settings. To bridge
this technology gap, Dr. Eric Peterson will lead Electronic BioSciences, Inc. (EBS), nanopore technology experts,
in developing a novel approach to nanopore-controlled sequencing that will yield state-of-the-art accuracy and
read lengths capable of assessing DNA repeats. During this program, EBS will demonstrate functionality of the
approach and fully assess the workflow/methodology, including accuracy, against current, standard approaches.
To initially characterize the feasibility and practicality of the proposed approach, EBS will also show the ability to
multiplex the measurement itself on a small scale, which will position the technology for extensive multiplexing
during a follow-on effort, a critical consideration for commercial adoptability. The capability to sequence repetitive
sequences with high accuracy and precision, and to identify their variations, will signify a major advancement in
cancer genomics, paving the way for improved diagnostics, prognostics, and therapeutics, which will lead to
better outcomes in cancer care.

Public health relevance
Project Narrative This project aims to pioneer a groundbreaking approach to nanopore-based sequencing that will enable the extensive repeat segments within genomic DNA to be assessed with ultra-high accuracy—a feat unattainable with existing sequencing technologies. Our novel pore-controlled sequencing methodology will significantly enhance the precision and reliability of identifying disease-specific variations within DNA repeats and enable the ability to correlate these changes diagnostics, prognostics, and therapy interventions. The development of this technology will not only fill a crucial gap in current genetic analysis capabilities but also propel the field of personalized medicine forward for more accurate, targeted, and effective cancer treatments.